Impact of Payment Methods on Service Delivery at Community Health Centers

Abstract
Community health centers (CHCs) are important safety-net providers that provide comprehensive preventive
and primary care to vulnerable populations in the United States, including Medicaid beneficiaries and the
uninsured. CHCs are also notable for providing the spectrum of primary care services, i.e., medical, mental,
and basic dental care within a single medical home. Our overall objective is to explore the impact of changes in
Medicaid reimbursement rate structures on utilization and costs of providing these co-located services in
CHCs, and on their financial position in general. To achieve this goal, we will first estimate regressions on
pooled all-state data for 2011, 2014, and 2018, the years for all states reported rate setting information to the
National Association of Community Health Centers (NAHCH), combined with the federal Uniform Data System
(UDS), which encompasses all individual CHCs. Similarly, we will analyze a balanced panel for the subset of
21 states reporting rate-setting in the full longitudinal sample, years 2011-2019, yielding 3,868 center-year
observations. In particular, we will evaluate effects of opting for the federal based PPS rates versus state
variations known as APMs, and the effects of imposing a single bundled payment rate per visit, i.e., the “all-
inclusive” rate, versus the bundled rates by services category (primary, mental, and dental care), known as the
service-specific rates. Given that in both the PPS or APM regimes, states may opt for either the inclusive rate
or service-specific methodologies, we will explore the interactions of these pairings of payment policies. We will
then examine the policy effects in a pooling of all years, and test for validity of a balanced or unbalanced
longitudinal design. In the panel data analysis, we will employ a fixed effect model, with CHC and year fixed
effects that leverages variations of state policies between states and over time within states. Corresponding to
Aim 1, for visits, we will explore volume in each service category separately, as well as the distribution (share)
of services. Corresponding to Aims 2-3, we will explore unit-costs and financial margins respectively. We note
that while the effects of Medicaid ACA expansions in the overlapping period are well documented in the earlier
literature (generally increasing both volume and costs), remarkably little is known about the effects of variations
in actual Medicaid payment methodologies for CHCs for these outcomes. Our study aims to fill this gap in both
the health services research literature and policy literature. With that, we will use a novel study design to
control the effects of the ACA Medicaid expansions to capture the separate effects of Medicaid payment
approaches.

Public health relevance
Project Narrative CHCs provide a unique setting for examining the delivery of integrated services in a primary care setting, yet there is a paucity of information on the impact of service-specific payment policies on the service delivery and activities. To fill this gap, we initiate new research, using a sample of 3,868 health center-year observations with complete policy information and other covariates.